Energy Metabolism in Osteoblasts and Bone Health

Energy Metabolism in Osteoblasts and Bone Health
Energy metabolism is an important regulator of cell fate and tissue homeostasis while its dysregulation is a
hallmark of aging in various tissues, including bone. Data on energy metabolism in osteoblasts (OB) are contra-
dictory, claiming OB reliance either on aerobic glycolysis or mitochondrial oxidative phosphorylation (OxPhos).
With regards to bioenergetic substrates, glutamine and fatty acids were recently shown to be as important for
OBs as glucose; and they are metabolized mostly in mitochondria. Our new exciting data suggest an explanation
to the above controversies and can reconcile the opposing views on OB metabolism. First, we confirmed that in
OBs, glucose metabolites do not reach the mitochondrial Krebs cycle but mostly flow into the pentose phosphate
pathway (PPP) and little into pyruvate and lactate. Actively proliferating and synthetic OBs likely benefit from this
setup as PPP provides NADPH for redox reactions, nucleotides, etc. Second, we found that OB mitochondria
actively metabolize glutamine, supplying not only the Krebs cycle but also cytosolic pyruvate and lactate due to
the malate-aspartate shuttle (MAS) activity and ensuing cytosolic reactions. This suggests a regulatory role of
mitochondria in the glycolytic process and PPP in OBs. Third, we found that in aged bone, there is mitochondrial
dysfunction and increased glucose metabolism to lactate and away from the PPP, and signs of oxidative stress.
Systemic inhibition of glucose flux to lactate using lactate dehydrogenase (LDH-A) inhibitor, oxamate, reverses
the glycolytic shift and ‘rejuvenates’ bone in aged mice. Our hypothesis is that in OBs, glucose preferential flux
into the PPP and glutamine-dependent mitochondrial activity supporting glycolysis and the PPP, is required for
bone maintenance and can be restored in aging by targeting LDH-A. This will be tested by characterizing the
role of PPP in OBs using loss-of-function (LOF) of G6PD, a key PPP enzyme (Aim 1); confirming the role of
mitochondria in supporting glycolysis and the PPP in OBs using inhibition of glutaminolysis or MAS (Aim 2); and
confirming LDH-A as a therapeutic target to reverse bone metabolic changes and aging using LDH-A LOF in
OBs (Aim 3). Altogether, this is expected to significantly enhance our understanding of how cell energy metab-
olism determines OB differentiation and function, explain existing controversies in the field, and suggest new
therapies for bone aging.

Public health relevance
Project Narrative The proposed research is relevant to public health because it has a potential to establish the role of osteoblast bioenergetic and redox processes in defining bone phenotype and provide a scientific basis for new therapeutic approaches for bone aging. It will also advance the field by elucidating yet unknown mechanisms connecting the unique metabolic setup in osteoblasts, i.e. mitochondrial/glycolysis/pentose phosphate axis with bone phenotype. This is highly relevant to the NIH mission of developing fundamental knowledge that will help to reduce the burdens of human aging and disability.